Leadership, Planning and Evaluation

LEADERSHIP PLANNING AND EVALUATION - ABSTRACT
University of Hawaiʻi Cancer Center’s (UHCC) Senior Leadership, led by Director Ueno, is structured to
facilitate collaborative and translational science and includes a Chief Scientific Officer, Associate Directors
[Shared Resources, Community Outreach and Engagement (COE), Cancer Research Training (CRT),
Translational and Clinical Research (TCR), Population Sciences, and Administration], and co-Program Leaders
for Cancer Biology, and Population Sciences in the Pacific. The UHCC Director also receives input from
Principal Investigators of major infrastructure grants, the Medical Director for the Clinical Trials Office, Cancer
Center Support Grant Coordinator, and leaders of the UHCC-based academic senate. This team of exceptional
individuals is charged with actualizing the mission of the UHCC, which is to reduce the burden of cancer
through research, education, patient care and community outreach, with an emphasis on the unique cultural
and environmental characteristics of Hawai‘i and the Pacific. The UHCC’s robust Planning and Evaluation
process is designed to periodically revise and strengthen our ongoing strategic plan and to identify and
establish new long-term strategic goals. Essential elements of this process are that it is responsive to needs of
our faculty and staff and to the needs of our catchment area, while also including regular review of the overall
strategic plans of UHCC by the Senior Leadership. Once new goals are identified, these are vetted by our
External Advisory Committee (EAC) on a yearly basis. Strategic goals are prioritized based on several criteria
including: 1) how well they contribute to furthering our institutional mission to reduce the burden of cancer in
Hawai‘i and the Pacific; 2) how well they build on UHCC research strengths centered on the unique cultural
and environmental characteristics of Hawai‘i and the Pacific; 3) how well they expand our research and clinical
efforts into new areas in response to catchment area needs and advances in cancer research; and 4)
availability of funds for the specific goal. We have various internal advisory committees, each dedicated to
specific areas such as patient-related matters, education, community engagement, faculty concerns, pilot
funding, membership, and UHCC space. These committees offer valuable input to the Director and Senior
Leadership team. Our EAC is structured to include members with various expertise appropriate to our Center.
It includes current and previous NCI cancer center directors, a cancer center administrator, a shared resource
director and four members with expertise related to our Cancer Biology Program (basic laboratory and clinical)
and four members with expertise related to our Population Sciences in the Pacific Program (prevention, cancer
control and population sciences). Three of these members also have extensive clinical trials experience. This
Leadership, Planning and Evaluation process has enabled the UHCC to put in place a vigorous and robust
process of vision setting, fostering discovery and advancing scientific discoveries, evaluating progress, and
planning for the future.